BUILDING CAPACITY TO EVALUATE INTERVENTIONS FOR YOUTH/YOUNG ADULTS WITH CHILD WELFARE INVOLVEMENT AT-RISK OF HOMELESSNESS: PHASE II

This project provides evaluation-related support for organizations awarded implementation grants for the further development and testing of interventions for youth with child welfare involvement who are most likely to experience homelessness. Key project tasks include conducting evaluability assessments, providing technical assistance on use of data required to inform implementation and continuous quality improvement activities and on the development of formative evaluation plans; and conducting a process evaluation of grantees' implementation processes and outcomes.